Equipment Supplement to Mechanisms and dynamics of allosteric function in proteins

Abstract (Parent Grant)
Included under Research Strategy.

Public health relevance
Narrative (Parent Grant) Protein allostery is a fundamental phenomenon in which ligand binding at one site affects substrate activity or ligand binding at a second, distal site of the protein. Allostery is a primary mode of regulation for enzymes and other proteins that drive signal transduction and metabolism, and it is now being used in some drug development efforts, even though the mechanisms of allostery are not well understood. The work in this project will characterize dynamics and allosteric communication pathways for the homodimeric enzymes chorismate mutase and thymidylate synthase, and for engineered optogenetic conformational switch proteins.